Investigating the role of endothelial cells in intestinal regeneration and disease

PROJECT SUMMARY
Significance: Intestinal dysfunction leads to diseases of enormous morbidity. Maintenance of intestinal stem cell
self-renewal and differentiation is dependent on extrinsic signals from the supporting niche. Despite their
abundance in the intestinal stem cell niche, the role of endothelial cells in supporting intestinal regeneration and
facilitating repair after injury, remain largely understudied. Recently, Dr. Brisa Palikuqi reported that lymphatic
endothelial cells, through the expression of the WNT modulator Rspo3, are essential for intestinal repair after
cytotoxic injury. Yet, the role of blood vessel endothelial cells in intestinal regeneration and their dysfunction in
inflammatory bowel disease, remains undetermined. By utilizing mouse models, immune profiling, single cell RNA
sequencing and spatial transcriptomics, this Mentored Career Development Award proposal seeks to gain a
comprehensive understanding of the role of blood endothelial cells in intestinal repair after injury and investigate
changes in the blood endothelial cell niche in models of inflammatory bowel disease.
Candidate and environment: The candidate for this Mentored Career Development Award, Dr. Brisa Palikuqi, is
committed to leading an independent research group at the intersection of the fields of intestinal biology, endothelial
cell biology and regenerative medicine. Dr. Palikuqi was trained in the laboratory of Dr. Shahin Rafii, at Weill Cornell
Medicine, where she developed a three-dimensional platform for the vascularization of organoids and islet
explants. During her postdoctoral studies at UCSF, in the laboratory of stem cell and developmental biologist Dr.
Ophir Klein, Dr. Palikuqi has studied the role of lymphatic endothelial cells in intestinal regeneration. As described
in her proposal, during the rest of the postdoctoral training and as she transitions to an independent position, Dr.
Brisa Palikuqi plans to examine the role of blood endothelial cells in intestinal regeneration and inflammatory bowel
disease. At UCSF, Dr. Palikuqi has assembled a team of mentors, advisors and collaborators that will support the
successful completion of her proposed research and training.
Career development: During the mentored period, the candidate will train in new techniques such as human and
mouse intestinal models of regeneration and disease, single cell RNA sequencing analysis, spatial transcriptomics
and immunology. The candidate will work closely with her mentoring team and enroll in complementary coursework
to acquire the necessary expertise to accomplish the research and career goals proposed in her application. She
will also undertake a program of training to support her professional development as a mentor and supervisor. A
central goal of the mentored period is for the candidate to obtain a Principal Investigator position. The execution of
the training in this proposal will equip the candidate with the necessary skillset and robust research platform to
launch her independent research career.

Public health relevance
PROJECT NARRATIVE Endothelial cells play a crucial role in supporting stem cell maintenance and regeneration in various tissues, yet their contribution in intestinal repair and regeneration remains poorly understood. The goal of this proposal is to investigate the function of blood endothelial cells and their secreted paracrine factors in intestinal repair, as well as to determine changes in blood endothelial cells in inflammatory bowel disease. Findings from these studies will have the potential to help develop strategies for modulating the endothelial cell niche to restore intestinal function in the context of disease conditions.